Microbial regulation of intestinal tuft cell homeostasis

Helminth infections and allergic diseases impact billions of individuals worldwide. While induction of type 2
immune responses are necessary for combatting helminth pathogens, inappropriate type 2 immunity triggers
inflammatory and allergic conditions. Therefore, improved understanding of mechanisms that control type 2
immune responses are needed. The intestinal microbiota continually influence immune responses, and several
studies have demonstrated that microbiota-derived factors dampen type 2 immunity. Intestinal tuft cells are
specialized epithelial cells that are essential for sensing luminal signals and initiating downstream type 2 immune
responses. My preliminary data indicate that the microbiota regulate tuft cell homeostasis and tuft cell-dependent
type 2 immune responses in the intestine. Studies outlined in this proposal will directly test (i) how intestinal stem
cells instruct tuft cell differentiation, and (ii) how commensal bacteria impact tuft cell-dependent type 2 immunity.
Collectively, these studies will provide new insights into how the microbiota direct intestinal epithelial
differentiation to instruct intestinal immune responses, and will guide novel microbiota-based approaches for
investigating and treating type 2-driven intestinal diseases.
My career goal is to establish myself as a successful investigator studying microbiota-regulated intestinal
diseases. To progress towards this goal, I propose in this application to dissect interactions between the
microbiota, epithelial cell differentiation, and mucosal immune responses. I will specifically concentrate on
developing expertise in four new areas that will facilitate my transition to independence: 1) gnotobiotics and
metagenomics, 2) type 2-driven murine disease models, 3) epithelial development and human intestinal
organoids, and 4) chromatin and single cell analyses. My mentors, Dr. Alenghat and Dr. Wells, along with the
exceptional scientific and intellectual environment at Cincinnati Children’s Hospital will enable me to utilize
modern, innovative approaches in my research and collaborate with top investigators. Over the next five years,
I fully anticipate that my background, in conjunction with the career development plan outlined in my application,
will allow me to successfully carry out the proposed project. The mentoring and training I will receive will enable
me to successfully transition to an independent research career directed towards fundamental advances in
intestinal immunity, as well as innovative and targeted strategies for investigating microbiota-sensitive diseases.

Public health relevance
Billions suffer from parasitic infections or allergic diseases that are regulated by type 2 immune responses in the intestine. The goals of this proposal are to understand the relationship between intestinal epithelial cells, microbiota, and type 2 immune responses. The outcomes of these studies will benefit human health because they will inform the design of new approaches for combatting allergic inflammation and improving intestinal immunity to fight infection.